RESEARCH AND DEVELOPMENT FOR BIOCOMPATIBILITY TESTING, ANIMAL STUDIES, AND STERILIZATION TESTING IN THE BLUEPRINT MEDTECH (BPMT) INITIATIVE - KICKOFF MEETINGS

Blueprint MedTech (BPMT): Biocompatibility, Animal Studies & Sterility Testing Support